Physiological regulation of energy intake at meals following weight loss

Project Summary/Abstract
Obesity is an urgent global epidemic demanding attention. A formidable obstacle in tackling obesity is the
tendency of weight losers to rebound. While multiple factors contribute to weight regain, we hypothesize that
heightened energy intake during meal events emerges as a primary driver of positive energy balance.
Understanding the regulation of meal energy intake is imperative in addressing this critical issue. This mentored
F32 proposal aims to investigate the physiological regulation of energy intake at meals following weight loss.
This research will involve analyzing energy balance and gut hormone data from the ARROW study
(R01DK114272), which aims to identify predictors of long-term weight loss maintenance in subjects who lose
weight through dieting with or without exercise compared to a control group with obesity. Additionally, participants
from the Time2Eat study (R01DK132372) will be leveraged to investigate gut hormones, metabolites, and
subjective measures of appetite before and after breakfast and dinner test meals in subjects engaging in early
time-restricted eating versus late time-restricted eating. Dr. Ezpeleta's background in intermittent fasting and
experience in analyzing energy balance physiology in his current T32 program uniquely positions him to
investigate these factors. Dr. Ezpeleta has assembled a team of mentors who have developed a comprehensive
training plan for his success. The plan includes developing expertise in energy balance, gut hormones, and
measures of appetite, designing and conducting clinical trials to analyze appetite in various weight statuses and
conditions, gaining proficiency in using quantitative questionnaires to assess eating behaviors, psychosocial
measures, appetite, and other ingestive behaviors, and enhancing his proficiency in clinical research methods
while receiving additional training in manuscript development, grant applications, and presenting research
findings. The research and training will take place at the University of Colorado Anschutz Medical Campus (CU-
AMC), which offers state-of-the-art resources, career development opportunities, and pilot grant funding.
Successful completion of this proposal will lead to five first-authored publications and generate thrilling
preliminary data to support a K-award application. In summary, this F32 proposal will expand Dr. Ezpeleta's
expertise in energy balance and appetite factors, contribute profoundly to the understanding of physiological
regulations behind meal energy intake, and assist in establishing Dr. Ezpeleta as an independent investigator.

Public health relevance
Project Narrative This F32 application aims to investigate physiological, psychological, and behavioral factors influencing appetite before, during and after meals in individuals with reduced obesity, aiming to understand mechanisms contributing to weight gain. The study's comprehensive analysis of meal energy intake seeks to bridge the gap in our understanding of positive energy balance drivers and disinhibition, providing valuable insights for targeted interventions. Successful completion of this F32 will equip Dr. Ezpeleta with expertise in mealtime appetite regulation and generate preliminary data essential for a K01 award, propelling them towards becoming an independent investigator.